Precision Medicine Initiative Cohort Program Biobank

PROJECT SUMMARY / ABSTRACT
In his State of the Union address on January 20, 2015, President Obama announced his intention to
launch the Precision Medicine Initiative (PMI). The goal of the PMI Cohort Program is to enroll one million
volunteers into a national cohort that broadly reflects the diversity of the U.S. population and accelerate
progress toward a new era of precision medicine on a larger scale than previously possible. The objective of
this proposal is to utilize the full resources available through the Mayo Clinic Biorepositories Program and
Mayo Medical Laboratories to efficiently and cost effectively support the activities of the PMI Cohort Program
with respect to the Biobank, namely, biospecimen collection, kit assembly, biospecimen accessioning, tracking,
processing, quality assurance, storage, and distribution. Mayo Medical Laboratories, the third largest reference
laboratory in the United States, will enable efficient specimen transportation, routing, and information
management between PMI collection sites and the Mayo Clinic Biobank. The aims of this proposal are to: (1)
To provide collection kits and leverage existing sample shipment logistics to ensure specimens arrive at Mayo
Clinic Rochester in the most expedient, efficient, and safe manner possible, in accordance with all federal and
state regulations; (2) Scale up existing state-of-the-art laboratory automation and robotics to process, label,
and store biospecimens, using established protocols compliant with laboratory best practices for all steps of
specimen handling; (3) Use our high-quality, robust, and secure research laboratory information management
system (RLIMS) for detailed tracking of sample receipt, processing, storage, retrieval, and distribution, while
protecting participant confidentiality; (4) Apply our comprehensive Quality Management Program to ensure all
work carried out is of the highest quality, and safeguard the collection with robust back-up systems and plans
for disaster recovery; and (5) Work closely with the Coordinating Center, Collection Sites, and all other PMI
Cohort Program Steering Committee Members to share biobanking expertise, infrastructure, and data to
further the goals of the PMI. Overall, the Mayo Clinic Biorepositories Program laboratories combined with
Mayo Medical Laboratories provide an unparalleled ability to collect, accession, process, distribute, store, and
manage virtually any type of biospecimen on behalf of the Precision Medicine Initiative Cohort Program.

Public health relevance
PROJECT NARRATIVE The Precision Medicine Initiative Cohort Program will enroll one million volunteers into a national Biobank that broadly reflects the diversity of the U.S. population and help accelerate progress toward a new era of precision medicine on a larger scale than previously possible. The proposed Biobank will be a valuable resource of biological specimens and related health information from human volunteers that can then be used to address a wide range of scientific questions to improve public health. Mayo Clinic proposes to provide a state-of-the-art infrastructure and cost-effective services to ensure the success of the Precision Medicine Initiative Cohort Program.